Short-Term Research Training Program in NIDDK Mission Areas

Substantive research training early during the course of medical school education is critical to address the declining number of physicians choosing research careers. The proposed University of Illinois Short-Term Research Training Program (SRTP) will provide first year medical students (12 slots in Year 1, 15 in Years 2-5) with a two month mentored research experience in the National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) mission areas including kidney, urologic and hematologic diseases; digestive disease and nutrition; and diabetes, endocrinology and metabolic diseases. The University of Illinois College of Medicine (UI COM) is the largest medical schools in the United States. The program will draw from first-year medical students at UI COM, as well as other medical schools in the Chicago metropolitan area and the Midwest. We have assembled an outstanding team of mentors in NIDDK mission areas with expertise in basic/mechanistic, clinical/translational, and behavioral/community-based research. In addition to mentored research, students will participate in an interactive, structured curriculum focused on research methodology, responsible conduct of research, and career development. To learn presentation skills and principles of rigor and reproducibility, students will co-lead, with a research mentor, journal clubs and works-in-progress sessions. Additional novel aspects of the program include the use of peer-to-peer mentoring and ongoing exposure to successful early career physician-scientists. At the end of the summer, students will present at the SRTP Research Symposium and the COM Research Day. After the program is completed, the program will utilize multiple strategies to facilitate continued involvement in research activities, including encouraging students to apply to the James Scholar Program, a program that provides the infrastructure to support research during the second to fourth years of medical school. In addition, the program will strive to create a sense of community among SRTP cohorts by hosting quarterly “Ideas on Tap” (research/social networking events at which students present ongoing research) and will maintain connections with trainees using the program website, newsletters, an SRTP Slack communication channel, and social media. An Executive Committee will oversee implementation of the program, recruitment/selection, program evaluation, and tracking of short- and long-term outcomes. Strengths of the program include the experienced co-Directors, committed and well-funded program mentors with broad expertise across NIDDK mission areas, an innovative structured curriculum, a robust recruitment plan, strong institutional support, and a thoughtfully conceived plan to foster continued research involvement after program completion. Consequently, the proposed SRTP will provide medical students with substantive research experience, facilitating the achievement of the long-term objective of increasing the pipeline of physicians entering the research workforce in NIDDK mission areas.

Public health relevance
The proposed University of Illinois Short-Term Research Training Program (SRTP) will provide first-year medical students with a two month mentored research experience in the National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) mission areas, including kidney, urologic, and hematologic diseases; digestive disease and nutrition; and diabetes, endocrinology, and metabolic disease. The proposed program brings together an outstanding team of established and emerging mentors with expertise in basic/mechanistic, clinical/translational, and behavioral/community-based research spanning NIDDK mission areas. In addition to mentored research, students will participate in an interactive, structured curriculum focused on research methodology, responsible conduct of research, presentation skills, and career development.